Partnering for Equity: An Academic and Community Alliance to Eliminate Disparities throughout the Fibroid Experience (PEACE)

Uterine leiomyomata or fibroids (UF) are the most common neoplasm in reproductive-age individuals and
represent one of the most significant racial disparities in reproductive health. Black women have higher
prevalence, higher incidence, more invasive surgical approaches, worse surgical outcomes, more
hysterectomies, and higher levels of treatment dissatisfaction than White women. Considerable evidence
indicates that race is a social construct, and thus we propose that social and structural determinants of health
such as chronic stressors and life events, discrimination/racism, psychosocial factors, education/knowledge, and
living conditions undergird some of the observed disparities in UF. The overall goal of this center proposal, titled,
Partnering for Equity: An Academic and Community Alliance to Eliminate Disparities throughout the
Fibroid Experience (PEACE), is to identify and quantify these social drivers of the observed disparities in UF
incidence, growth, treatment pathways, and patient experiences between Black and White women. Our goal is to
provide the much-needed data to identify solutions and interventions to reduce these disparities and improve the
health and well-being of Black women with UF and all women with UF. This Center will be guided by the principles
of Community-Based Participatory Research (CBPR), in which community members, stakeholders, and
researchers work in partnership to conduct research that is equitable in process, resources, accountability, and
responsibility. We will leverage the expertise of our community/academic partners to focus on socio-cultural
drivers of UF incidence, growth, treatment pathways, and patient experiences. To take on this extraordinary
problem, we have assembled an extraordinary team of community members and investigators who have worked
together for months to build the PEACE Center from the ground up. The Center team represents an incredible
range of expertise, from UF clinical, CBPR, and epidemiological experts, to national and global leaders who are
new to UF, but bring vast experience in health disparities, health equity, African American history and culture,
sociology, health services, health behavior, and health intervention. We propose three highly multidisciplinary and
innovative research projects for this center: Project 1- Racial Disparities in UF Care Pathways; Project 2- Multiple
Stress Pathways and Positive Resources in UF Incidence and Growth; and Project 3- Centering Patients:
Development of a Tailored eHealth Intervention to Improve the UF Patient Experience. Two core facilities will
support the research projects: an Administrative Core and the Community Partnership, Education, and Outreach
Core. Internal and External Advisory Boards will provide scientific input biannually and yearly, respectively. The
PEACE Center will include a Pilot Grant Program for Early-Stage Investigators and a Community Dissemination
Grants Program for community organizations. Together, we anticipate that the results obtained from these
projects and this alliance will increase health equity throughout the UF continuum and will improve the health of
those diagnosed with and most burdened by this highly prevalent and morbid disease.

Public health relevance
Modified Public Health Relevance Section The proposed Projects in PEACE have and will continue to actively engage community partners throughout all phases of the project. By using a CBPR approach, the effectiveness of the proposed research to decrease health differences will be greatly enhanced by the active, ongoing engagement of the communities directly experiencing a disproportionate fibroid burden—Black women. CBPR partnerships embrace principles of mutual respect, power sharing, co-learning, balancing research and action, and a long-term commitment to achieving health and well being across all communities .All partners contribute expertise and share decision-making and ownership to increase knowledge and understanding, then integrate that knowledge with interventions to promote health.